Research Infrastructure for the study of Alzheimer's Disease and Alzheimer's Disease-related dementias in older Asian Americans

PROJECT SUMMARY
The older Asian American population has been rising, with the risk of Alzheimer’s Disease and Alzheimer’s
Disease-Related Dementias (AD/ADRD) also increasing. However, most of the disparities in health outcomes
are masked because older Asian Americans are significantly underrepresented in clinical research. Social
determinants of health (SDOH) are an individual’s personal circumstances that influence their health and well-
being. SDOH contribute to wide health disparities and inequities. Research linking AD/ADRD to SDOH is
expanding rapidly, yet much evidence is still needed in older Asian Americans. Additionally, there are relatively
few studies incorporating health related risks, such as vascular conditions, and biomarkers to understand the
link between SDOH and AD/ADRD; it remains unclear if vascular risk factors and/or biomarkers mediate such a
relationship. Using validated cognitive tests in English/Chinese and culturally relevant measures of
sociodemographic factors, the study MPI (Li) successfully enrolled over 200 older Asian Americans in clinical
research at the Alzheimer’s Disease Research Center (ADRC) at Mount Sinai. Here, the study team will grow to
include multidisciplinary members, proposing a 5-year study to develop a research infrastructure for studying
AD/ADRD in older Asian Americans. The SDOH assessment will be available in English, Mandarin, and
Cantonese – the most common spoken languages among Asian American older adults. This study will answer
the following questions: (1) Do Chinese translation and cultural adaptation of SDOH measures effectively recruit
new and existing older Asian Americans in AD/ADRD research? (2) Can we identify behavior, environmental,
social, genetic, and neurobiological factors associated with AD/ADRD? (3) How neurobiological processes
intersect with environmental, sociocultural, behavioral, and other demographic factors to affect AD/ADRD
outcomes? The study team will establish a scientific advisory board to provide scientific perspectives for the
proposed study, particularly in the areas of (1) Social science; (2) Clinical phenotypes of AD/ADRD; (3) Dementia
research in Asian Americans; and (4) Risk factors and biomarkers for AD/ADRD. The team will also collaborate
with key community stakeholders to ensure that the SDOH assessment is culturally and linguistically appropriate.
Recruitment goal is set to be 300 older Asian Americans to complete a comprehensive dementia evaluation that
includes SDOH measurement. Novel, theory based SDOH indices will be developed to characterize older Asian
Americans in the normal, MCI, and AD/ADRD groups. Of the 300 enrollees, the study team aims to re-evaluate
100 participants for a 1-year follow-up and collect 200 biomarker samples for molecular profiling, including whole
genome sequencing, RNA-sequencing and proteomics. An integrative network biology and machine learning
based approach will be employed to develop highly predictive diagnostic and prognostic molecular biomarkers
of AD/ADRD. The UH2 phase will be used to develop the research infrastructure and assessment tools
necessary to apply for a larger RO1 project at the end of the UH3 phase.

Public health relevance
PROJECT NARRATIVE Despite the rapidly growing population of older Asian Americans, their participation in clinical research for Alzheimer’s Disease and Alzheimer’s Disease-Related Dementias (AD/ADRD) remains historically low – masking health disparities in this minority group. Social determinants of health (SDOH) are the conditions in the environment that affect an individual’s overall health and quality of life. This proposed study will investigate mechanisms involved in the relationship between SDOH and AD/ADRD outcomes, as well as identify vascular risk factors and novel biomarkers for predicting AD/ADRD using modern systems biology and machine learning based approaches.